Mechanistic Effects of Health Coaching to reduce COPD Hospitalizations

PROJECT SUMMARY/ABSTRACT
The overarching goal of the proposed research is to study further aspects of health coaching, an intervention
that led to the first randomized evidence that health coaching reduces re-hospitalizations in chronic obstructive
lung disease (COPD). The proposed study of the mechanistic effect of this intervention will lead to the creation
of a theoretical framework of how the intervention works. We will further test the effect of health coaching on
the quality of life and daily physical activity of a patient with severe symptoms of COPD in a small but powered
randomized study. General goals: The proposal will provide Roberto Benzo, MD, MSc, with protected time to
extend his mentorship of junior future NHLBI researchers and also expand his research program. Specific
aims: Dr. Benzo plans to increase his time mentoring investigators from the Pulmonary Medicine and Critical
Care Program at Mayo Clinic, students from the Mayo Clinic Graduate School of Biomedical Sciences, and
Mayo Center for Clinical and Translational Science scholars. He will also perform the mechanistic analysis of
his recent NHLBI-funded randomized study identifying the benefits of health coaching which decreases
hospitalizations for COPD and expand the study of the effectiveness of health coaching in another disease
group. Qualifications: Dr. Benzo is a tenured Associate Professor at Mayo Clinic, with a strong record of
research, publication, and mentoring. His K23 career development award, training in epidemiology at Harvard
University, two subsequent R01s, and multiple SBIRs have developed his background as an ideal candidate
for this application. He currently leads the Mindful Breathing Lab at Mayo Clinic, an NIH-funded lab devoted to
patient-oriented research in lung disease. Environment: The proposed K24 grant will be executed through the
Division of Pulmonary and Critical Care at Mayo Clinic, which was ranked #1 in the United States in the last
two consecutive years by the U.S. News & World Report. Mentoring program: Dr. Benzo presently mentors
junior faculty, pulmonary and critical care fellows, resident physicians, and graduate students. Several mentees
are engaged in NHLBI research, including one who was recently awarded a K23 from the NHLBI. Mentees:
Dr. Benzo will solidify and expand his mentoring program with the assistance of this grant. The program's
resources and reputation will attract an increasing pool of the most qualified and promising future NHLBI
researchers. Training: Dr. Benzo will undertake substantive training to plan, execute, and analyze patient-
oriented studies. Research: The proposed research will build on Dr. Benzo's previous work, especially the
published findings of his recent NHLBI-funded R01 study. Significance: This grant will facilitate the
development of the next generation of NHLBI patient-oriented researchers and will support the ongoing
research implementing the intervention that focuses on what matters to patients.

Public health relevance
PROJECT NARRATIVE This Midcareer Investigator Award in Patient-Oriented Research will support Roberto Benzo to 1) provide dedicated mentoring to promising researchers with interest in behavioral intervention in chronic lung disease, and 2) expand his research program. The specific research proposed would expand knowledge regarding the effect of an intervention tested in an NHLBI-funded randomized study that decreased hospitalization in chronic obstructive lung disease.